Developmental neurotoxicity and autism spectrum disorder

Project summary
The Emerging Global Leader Award (K43) aims to advance the career development and research activities
of Dr. Omamuyovwi Ijomone, a Senior Lecturer/Researcher at the Federal University of Technology, Akure,
Nigeria. Dr. Ijomone’s overall research goal is to contribute novel information to understanding the
mechanisms of neuronal degeneration. Particularly, he aims to understand how the brain is affected by an
interplay of genetic and environmental factors that trigger neuronal death at critical stages of development.
Neurodevelopmental disorders are diverse conditions resulting from aberrant brain development. Autism
spectrum disorder (ASD), amongst other conditions, falls in this category. The etiology of these diseases is
not fully understood; however, it involves gene-environmental interplay. Environmental overexposure to
heavy metals, specifically nickel (Ni) and manganese (Mn), have been linked to ASD pathogenesis. During
this program, Dr. Ijomone’s research will pioneer the use of the innovative Caenorhabditis elegans model in
the Nigerian biomedical research community, to investigate the role of ASD risk genes, NRXN and NLGN,
in morphological, behavioral, and molecular alterations caused by developmental Ni and Mn exposures. His
research approach will build on gene expression and genetic analysis methodological toolkit to specifically:
1) investigate the role of NRXN and NLGN in neurodevelopmental deficits of Ni and Mn exposures; and 2)
elucidate molecular mechanisms underlying neurodevelopmental deficits of Ni and Mn exposures upon
NRXN and NLGN mutations. Dr. Ijomone’s career development goals for this program are to: 1) build on
existing, and acquire new knowledge and skills to effectively design and tests hypothesis-driven
translational research ideas; 2) improve grantsmanship and manuscript writing skills, as well as improve
skills for effective communication of scientific findings to policymakers and the general public; and 3)
contribute to the scientific platform in Nigeria and build local research capacity. Dr. Ijomone will undertake
this program under the collaborative mentorship of Prof. Michael Aschner (USA mentor), Prof. Ganiyu Oboh
(Nigeria mentor), and Prof. Herbert Lachman (Co-mentor, USA). Prof. Aschner is a leading
neurotoxicologist with research interest in genetic and environmental interplay during CNS development
and senescence. Prof. Oboh is a top Nigerian researcher with expertise that include toxicology and
neuroprotection. Prof. Lachman is physician and behavioral geneticist interested in the molecular and
genetic basis of neurodevelopmental disorders including ASD. Prof. Janis Weeks (USA), a Professor
Emerita with extensive experience in using the C. elegans model for translational research will provide
additional guidance. Dr. Ijomone will use the K43 award in a structured research and training program to
enable him to develop into a fully independent investigator and a scientific leader.
1

Public health relevance
Project narrative Increasing evidence associates exposure to environment toxicants such as heavy metals to negative neurological consequences, particularly, perinatal exposure to heavy metals is increasingly linked to neurodevelopmental disorders. Our study aims to investigate morphological, behavioral, and molecular alterations caused by developmental exposure to heavy metals in relation to endpoints of autism spectrum disorders (ASD). Our proposal will provide novel translational information on the importance of inherent genetic differences and exogenous chemical perturbations of cellular processes as potential modifiers of metal-induced neurotoxicity and neurodevelopmental disorders such as ASD; thus, laying the groundwork for innovative therapeutic strategies against neurodevelopmental disorders.